ORAL GI26257OX IN PATIENTS W TYPE II DIABETES MELLITUS

GI262570X is a potent, selective, non-thiazolidinedione PPAR agonist. This compout has demonstrated anithyperglycemic and lipid-lowering activity in rodent models of Type 2 diabetes mellitus (DM). GI262570X, therefore, has the potential to ameliorate the hyperglycemia and dyslipidemia associated with Type 2. It is about 1000-fold more potent than troglitazone (a thiazolidinedione antidiabetic agent) in vitro and shows greater selectivity for the PPAR receptor. It is hypothesized that this greater potency and selectivity will translate into improved glycemic control (as measured by glycosylated hemoglobin, HbA). This study will investigate the safety and efficacy of GI262570X in patients with Type 2 DM..